Discipline B - Chemistry: Animal Food Product Testing - Analytical Tracks 1 - 3

Abstract PROJECT SIX: Texas Animal Food Product Testing for Chemical Hazards The OTSC Animal Food Surveillance of Chemical and Environment Hazards project includes: 1) sampling and analyzing 600 products for chemical hazards, 2) Removing adulterate product from market, and 3) expanding OTSC-AAS analytical methodology to encompass target analytes including cannabis (year 1), pentobarbital (year 2), ethoxyquin (year 3), and glyphosate and acid herbicides (year 4). The Texas Animal Food Product Testing for Chemical Hazards project includes analyzing surveillance samples as follows: 200 rendered products for toxic metal analysis; 200 pet food products for aflatoxin analysis and vitamin D, and 200 distiller grains, wheat midds, and similar products for fumonisin and zearalenone. OTSC is the Texas regulatory agency that has the authority collect and analyze these samples in their ISO/IEC 17025:2017 laboratory and perform regulatory compliance activities to remove adulterate product from the market. These surveillance samples will be built into the OTSC regulatory Plan-of-Work (POW), which is developed annually using procedures contained in SOP F0032 in fulfillment of AFRPS standard 8 and 11. The POW is statistically derived and risk-based. The sample collection and analysis strategically capture market activities and balance the chemical hazard surveillance with laboratory throughput to meet the OTSC 10-day turnaround time goal. OTSC lab is staffed by 13 analysts, a laboratory quality manager, and 4 laboratory attendants. The lab is equipped with current and well maintained instrumentation. OTSC regulatory personnel include 14 field investigators who are qualified to collect samples for chemical and microbiological analysis using official procedures and has the authority to remove adulterate product from the market. As an outcome of this project, Texas animal food testing for chemical hazards will be strengthened, scope of ISO accreditation expanded to include more chemical contaminants through method development, validation and implementation into the OTSC laboratory resulting in capacity and capability increase.